Pragmatic predictive model of placental dysfunction to guide key clinical decisions

PROJECT SUMMARY/ABSTRACT
Placental dysfunction causes more than half of preventable stillbirths in the United States. Placental
dysfunction also causes preeclampsia and fetal growth restriction, both of which can represent near misses for
stillbirth. Tools for preventing stillbirth due to placental dysfunction include heightened fetal surveillance and
recommending early delivery for known at risk pregnancies. However, these tools are only effective if we can
accurately detect which pregnancies are at increased risk of placental dysfunction and stillbirth. Thus,
accurately predicting risk of placental dysfunction is key to stillbirth prevention. The current national
guidelines to identify high-risk pregnancies are based on presence of individual risk factors and do a poor job
of accurately categorizing pregnancies. This is in part due to lack of quantitative assessment of cumulative risk
or use of biomarkers of placental health. A predictive model can both calculate cumulative risk from multiple
factors and incorporate biomarkers into risk calculations. If we can accurately calculate individual pregnancy
risk of placental dysfunction, we will be better able to prevent stillbirths using fetal surveillance and early
delivery. Our long-term goal is to improve prediction and prevention of stillbirth. We propose using a predictive
model to determine individual pregnancy risk of placental dysfunction. The main objective of this project is to
externally validate and optimize our existing clinical predictive model of placental dysfunction to enable
individual risk assessment for preventable stillbirth. Aim 1: Validate and update a novel predictive model of
individual risk of placental dysfunction. Aim 2: Measure incremental benefit of adding biomarkers of placental
health to the predictive model and determine the optimal combination of biomarkers to guide fetal testing and
timing of delivery. Aim 3: Conduct cost-effectiveness analysis (CEA) of clinical implementation of predictive
models of placental dysfunction, both with and without key biomarkers. Predictive models calculate a predicted
probability, or risk, of a specific outcome. With knowledge of individual risk, use of tools to prevent stillbirth can
be customized by degree of predicted risk (i.e., recommending the most intense surveillance and earlier
delivery to those at highest risk). To test Aims 1 and 2, we will enroll 640 pregnant people and follow them
throughout pregnancy, checking biomarkers (ultrasound and blood tests) at three time points. We will then
identify the combination of biomarkers and clinical variables that best predict placental dysfunction. We have
selected biomarkers that are already clinically available to ease future translation to real world use. To achieve
Aim 3, we will build decision analytic models for using predictive models to inform decisions regarding both use
of antenatal surveillance and timing of delivery. Models will be prioritized based on performance, cost-
effectiveness, and practicality. Upon completion of this project, we will have an updated, optimized predictive
model of placental dysfunction including clinically meaningful biomarkers along with CEA to inform the
economics of implementation in future projects.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because the findings will improve our ability to correctly identify who is at increased risk for preventable stillbirth due to placental insufficiency. With improved knowledge of individual pregnancy risk, we can then better employ tools like antenatal fetal surveillance and early delivery to reduce stillbirth. The proposed project is relevant to the mission of the NICHD to improve reproductive health as highlighted in the NICHD Stillbirth Working Group's March 2023 call for work to translate knowledge of risk factors of stillbirth into interventions and improve determination of risk.